Functional protein networks underlying T cell growth, proliferation and differentiation

Project Summary:
Proper immune function is pivotal to the human health. CD4+ T cell is a central component of adaptive
immunity to coordinate both innate and adaptive immune responses. Immune suppressive regulatory T (Treg)
cells are pivotal in immune homeostasis and self-tolerance, and their function is controlled through quite
diverse mechanisms, allowing Treg cells to respond appropriately to diverse environmental cues to ensure
proper immune response. It is important to investigate the functional protein networks underlying T and Treg
cell function in immune homeostasis and diseases. We have identified many critical factors, pathways, and
mechanisms for T and Treg cell function in the last funding period, during which we revealed an unexpected
critical role for an innate senor AIM2 (Absent In Melanoma 2) in controlling Treg cell function in a recent study.
We found that AIM2 is expressed at much higher levels in Treg cells than in innate cells, in both human
and mouse. TGFβ promotes AIM2 expression coinciding with Treg cell generation. Unlike Asc-/- and ICE-/-
(caspase-1-/-11-/--) mice that are resistant to EAE, Aim2-/- mice developed more severe EAE than WT mice.
AIM2 deletion leads to reduced Treg cell function during inflammatory diseases such as EAE. AIM2 is required
for Treg cell stability to mitigate EAE. AIM2-deficiency leads to the hyper-activation of Akt-mTOR signaling to
attenuate Treg cell function with altered immune metabolism. These exciting findings prompt us to hypothesize
that the expression and function of AIM2 in Treg cells are controlled through mechanisms both distinct from
and shared with those found in the innate cells, to uphold tolerance and restrain autoimmunity. To test this
hypothesis, we strive to reach the following research aims. AIM 1: Reveal the genetic and molecular
mechanisms of TGFβ promoted Aim2 expression in Treg cells. AIM 2: Investigate if AIM2 controls Treg cell
function by integrating DNA-sensing function and inflammasome components. AIM 3: Mechanistic study of the
functional AIM2-interacting protein network underlying AIM2 controlled Treg cell function.
This proposed study will highlight a previously unappreciated critical role for AIM2 in Treg cells. It will
revise the current paradigm for the function of AIM2 by incorporating its Treg cell specific function. It will
provide new insights into how Treg cell generation and function can be regulated. It will shed new lights on the
molecular networks underlying Treg cell function and to reveal potential novel molecular targets and therapies
for autoimmune diseases.

Public health relevance
Project Narrative: T cells and immune suppressive regulatory T (Treg) cells are pivotal in immune homeostasis and diseases. It is critical to understand the functional protein networks underlying T and Treg cell function. Our recent study revealed an unexpected critical role for innate senor AIM2 (Absent In Melanoma 2) in controlling Treg cell function to mitigate autoimmune EAE, by modulating Akt-mTOR signaling. Based on these exciting findings, we propose to study how the expression and function of AIM2 in Treg cells are controlled through mechanisms both distinct from and shared with those found in the innate cells, to uphold tolerance and restrain autoimmunity. This study will highlight a previously unappreciated critical role for AIM2, shed new lights on the molecular networks underlying Treg cell function, and reveal potential novel molecular targets and therapies for autoimmune diseases.